DEFINING REGULATORS OF RNA POLYMERASE I FUNCTION IN S CEREVISIAE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We are using mass spectrometry combined with in vitro activity assays to identify specific factors or modifications that affect Pol I activity in response to a variety of treatments (amino acid starvation, antibiotics, etc.).